Supplement U-RISE Program at Delaware State University

Supplement U-RISE Delaware State University: Student Training in Academic Research (STAR) Summary: This proposal is to request supplemental support for designing complementary online activities that will be integrated synergistically with those of the U-RISE program at Delaware State University (DSU). These activities are in response to the unexpected COVID-19 outbreak and its impact on DSU and U-RISE program, compelling the program to consider offering many of its skill-development workshops online and to design new computational-driven training modules virtually. The U-RISE training site at DSU is established as a catalyst to attract, and to closely train, up to 12 undergraduate students per year in any of the biomedical research disciplines, totaling up to 36 trainees over the five-year period of the grant. Our STAR Scholars will be mentored and motivated to ultimately pursue their PhD degree and careers related to biomedical research. DSU, an Historically Black University (HBCU), enrolls about 4800 undergraduate students, with over 70% being members of racial and ethnic minority groups that are traditionally underrepresented in STEM. Based on best practices from the literature, we will implement an educational and research training program that will support successful graduation of our scholars and ensure that they are accepted to biomedically-related graduate programs, are motivated to attend, and are prepared for success. Our STAR Scholars will participate in two summer research internships, first on the DSU campus, and the second at a research intensive institution. Through the IDeA Networks of Biomdical Research and other connnections, we have identified a large number of partner institutions who will host our STAR Scholars in their summer undergraduate research programs, ensuring that they are matched with trained, experienced mentors. To support our Scholars, we have designed a series of activities, courses, and workshops that will provide knowledge and skills development to support academic success at DSU and in graduate school. Our Scholars will be supported by strong, culturally-competent mentors, who have completed an on-line mentoring course and participate in interventions shown to minimize implicit bias. To increase STEM engagement and self-efficacy and strengthen critical thinking skills among the broader STEM student community at DSU, our program supports professional development to faculty to integrate course-based undergraduate research experiences (CUREs) into introductory STEM courses. We expect these early research experiences to increase retention and motivate more students toward careers in research. We aim that 90% of our DSU-STAR trainees graduate with a bachelor’s degree in a STEM discipline, at least 60% of our trainees pursue a biomedical Ph.D or Ph.D/M.D. degree at a research intensive institution, and at least 80% of those matriculants obtain their degrees. Furthermore, the DSU STAR program will also support initiatives to increase the four and five year graduation rate from 25% to 35% and 38% to 50%. Finally, we will establish assessment mechanisms to evaluate the program, to ensure its continuous success.

Public health relevance
Public Health Relevance Today’s biomedical researchers represent the backbone of innovation that improves public health nationwide. However, they have little resemblance to the overall diverse populations they are part of, causing increases in disparities in health access and outcomes. Together with the new proposed online activities of this Supplement the U-RISE site at Delaware is to promote diversity of the workforce in biomedical research. Being a Historically Black University, DSU is well positioned to significantly contribute towards this goal as its undergraduate student population is about 80% minority, mostly underrepresented in diverse STEM fields.